Elucidating Cellular Aging and Quality Control Pathways through Meiotic Differentiation

PROJECT SUMMARY
The primary risk factor for prevalent diseases including cancer and neurodegeneration is aging. At the cellular
level, aging manifests as an accumulation of conserved physiological defects that eventually cause functional
decline, disease, and organismal death. Despite an extensive list of age-associated dysfunctions, we have a
limited understanding of how aging becomes a major disease determinant. The traditional method in the field is
to induce genetic modifications in a model organism before the aging process manifests itself, and to
subsequently determine how these alterations affect lifespan. While these studies have been instrumental in
identifying factors that impact longevity and healthspan, they lack the temporal resolution to distinguish the
gene products that directly counteract age-associated damage from those that have indirect effects on lifespan,
merely through delaying cell cycle progression, growth and/or development. The key challenge is the
development of an effective system that allows identification of the underlying mechanisms of aging and
manipulation of identified factors in a controlled manner. My lab has discovered that gametogenesis, the
differentiation program that gives rise to reproductive cells, contains endogenous rejuvenation pathways.
These physiological pathways have the ability to exclude and eliminate both cytoplasmic and nuclear
pathologies that are associated with age. Therefore, mechanistic dissection of this program offers unique
insights into the biology of aging as well as potential therapeutic avenues for age-associated diseases.
This proposal seeks to provide a comprehensive understanding of the molecular and cellular events
that are associated with meiotic rejuvenation. The experiments proposed in Aim 1 will determine how gametes
are able to exclude and subsequently eliminate nuclear and cytoplasmic defects that accumulate with age. The
experiments proposed in Aim 2 will take an orthogonal approach to identify and characterize the complete
complement of meiotic genes that are capable of extending lifespan in vegetative yeast cells, akin to metazoan
somatic cells. Further extension of these studies to C. elegans will identify conserved meiotic genes that can
counteract organellar damage and will determine the effects of activating gametogenesis-specific rejuvenation
pathways on tissue-specific as well as organismal healthspan. The combination of studies described in this
proposal will reveal a mechanistic understanding of how meiotic rejuvenation occurs at the molecular level,
determine which genes improve fitness and lifespan outside of meiosis, and reveal conserved pathways that
can be leveraged to extend healthspan.

Public health relevance
PROJECT NARRATIVE Public Heath Relevance: This proposal will provide us with an understanding of how gamete formation ensures cellular fitness and counteracts cellular aging. The findings have potential impact in the areas of age- associated diseases including cancer and neurodegeneration, regenerative medicine and reprogramming.